Functional and Neuroprotective Effects of Restoring Lower Limb Sensation after Diabetic Peripheral Neuropathy

Thus project addresses a gap in the available interventions for Veterans with Diabetic
Peripheral Neuropathy (DPN), a large and growing chronic disease population within the VHA.
Individuals with diabetes have a 10-times higher risk of amputations than the general
population. We expect that discrete, meaningful sensations perceived to be arising from the
missing foot can be chronically elicited by multi-contact peripheral nerve cuff electrodes
installed on the nerves in the thigh above the knee of Veterans with lower-limb loss due to
DPN. We anticipate that these electrically elicited sensations can maintain the health and
resiliency of the residual limb and provide meaningful feedback during daily activities. We will
rigorously document medical and medication history, and the interactions of the ongoing
disease with the implanted components, and expect them to be well tolerated by volunteers
with minimal clinical complications.
Amputees pay less attention to their feet, are at risk for complications affecting the skin and
underlying tissues of their residual limb due to routine prosthetic socket use. We expect that
eliciting sensation perceived as arising from the missing foot via neural stimulation will improve
the health of the residual limb tissues of Veterans with limb loss due to DPN, and make them
more resilient to potentially damaging loads. That is, circulation and residual limb tissue health
will improve, and the likelihood of developing complications will decrease with the restoration
of appropriate sensation. Therefore, physiological measures of blood flow, temperature,
transcutaneous oxygen and other indicators of underlying tissue health, as well as the and
frequency and severity of phantom pain will change as a result of this unique intervention.
The sensations perceived as related to physical interactions of the prosthesis with the
environment elicited with neural stimulation will also improve standing balance, walking
mechanics, and overall confidence and activity levels of Veterans with lower-limb loss due to
DPN. Standing balance and sway, and the ability to adapt to challenging or changing
environments, as well as subjective assessments of attention, balance confidence and fear of
falling measured with and without sensory stimulation. We further anticipate that recipients of
our Sensory Neuroprosthesis who have DPN will find it valuable in the home and community
as evidenced by patterns of usage, total standing and walking time, and subjective ratings of
satisfaction and effort. We expect users to have increased mobility, and cope more effectively
with disturbances to gait and balance.
We will recruit and enroll a total of five new participants who will receive the surgically
implanted systems, and act as their own historical (pre- and post-implantation) and concurrent
(with and without sensory stimulation) controls. The Sensory Neuroprosthesis previously
developed by our group for traumatic trans-tibial amputees consisting of a wireless pressure
sensitive insole and external neural stimulator will be adapted for the unique clinical needs of
Veterans with DPN to deliver stimulation to the nerve via selected nerve electrode contacts at
the appropriate intensity corresponding to physical input to the foot. The successful
completion of this project will yield the information required to define the requirements for the
design of a self-contained system for Veterans with limb loss due to DPN that will be suitable
for larger scale clinical trials or commercially-sponsored projects.

Public health relevance
This study will directly impact the health and well-being of Veterans who have lost a lower limb due to Diabetic Peripheral Neuropathy (DPN). Over 20% of Veterans are diagnosed with diabetes, which makes it the second largest chronic disease population in the VHA. DPN is the most common complication associated with diabetes, and is responsible for about 62% of amputations among Veterans. The goal of this project is to reduce reports of phantom pain and improve overall health of the residual limb, thereby reducing the ongoing risk of complications from daily prosthesis use and loading imposed by the prosthetic socket. In parallel, we will enhance the balance, gait stability and activity levels of Veterans who have lost a limb due to DPN by providing feedback of foot-floor interactions via direct neural stimulation of the sensory nerves above the knee. We will achieve this adapting our successful approach to restoring perception of foot-floor contact that has already been demonstrated after traumatic limb loss to the specific clinical needs of Veterans with DPN.